Gaining insight into psychiatric disease by engineering piece by piece the human brain in vitro.

ABSTRACT
A critical challenge in understanding the intricate programs underlying development, assembly,
function, and dysfunction of the human nervous system is the lack of direct access to intact,
functioning human brain tissue for detailed investigation by imaging, recording, and stimulation.
My laboratory has been developing methods for directed differentiation of region-specific brain
organoids and we have shown that these can combined two by two to study cell-cell interactions
and circuit formation in preparations called brain assembloids. However, current in vitro brain
models derived from stem cells do not capture neuromodulatory input, which restrict broader
applications in neuroscience and modeling of disease. Here, we propose to develop a human 3D
cellular platform that includes neuromodulatory projections. More specifically, we will derive
from pluripotent stem cells regionalized brain organoids resembling the nucleus raphe in the
brainstem and containing serotonergic neurons, and subsequently assemble them with cortical
organoids. Using state-of-the-art live imaging, transcriptomics, pharmacology, viral tracing and
electrophysiological methods, we plan to study serotonergic input into the cerebral cortex and use
this platform to investigate defects in neuronal cross-talk in a severe genetic form of
neurodevelopmental disease.

Public health relevance
NARRATIVE The slow pace of progress in understanding brain disorders is partly due to a lack of access to live neurons from patients for detailed investigation by imaging, recording, and stimulation. We propose to build the next-generation, in vitro organoid models of human brain function by including neural projections that release modulatory molecules. We plan to use this novel system to understand how communication between brain regions goes wrong in genetic neurodevelopmental disorders and to identify means to reverse these defects.